Administrative

The objective of the Administrative Core is to coordinate all the interactions of the Program Project's various components internally and externally. In practice the Administrative Core will be the working center of the Program Project bridging the many staff of the Clinical Centers with the staff of the scientific cores and managing all the regulatory and administrative duties of a large, multi-project endeavor. Its primary goals will be to: 1) manage the administrative duties so efficiently that the Principal Investigator can concentrate on developing the science proposed, 2) support the three scientific projects and their staffto optimize their productivity, 3) create the constructive working relationships at the administrative level that are so critical for a Program Project to function successfully, 4) support the Clinical Center Investigators and the Study Coordinators so that the critical task of patient enrollment, specimen acquisition, shipping and follow-up is facilitated and the work of the Study Coordinators at the Centers is efficient and productive, 5) manage the complex sample and data generation from the Centers, the Clinical Database, the movement of materials from Scripps to UC, San Francisco for Project 3, support the two scientific projects at Scripps so that the integrity of the data set created is insured to enable the critical task of finding the correlations between genomic profiles and clinical events and outcomes in kidney transplantation, 6) insure the data is made accessible to the public at the Program Project web site to facilitate outside analysis and advance the entire Field's efforts to understand the biology of transplantation.